Dual-function Carbon Modified-Silicon Microelectrodes for Biomolecule Detection with Fast Scan Cyclic Voltammetry and Electrophysiology Recording and Stimulation

Abstract
In both neuroscience research and clinical practice, measurements predominantly focus either on neurochemical
or electrophysiological function within the nervous system. This bifurcated approach limits our comprehensive
understanding of the nervous system. Ideally, simultaneously recording both multichannel electrophysiological
and neurochemical biomarkers would provide a more complete view of neurological function, paving the way for
dynamic, multi-biomarker, closed-loop solutions. Such advancements would address a significant clinical need,
for the treatment and of study neurological disorders such as Parkinson’s Disease, depression, and drug abuse.
Over the last decade, Dr. Alexander Zestos has developed carbon-based microelectrodes to simultaneously
detect multiple neurotransmitters using Fast-Scan Cyclic Voltammetry (FSCV). Additionally, he has integrated
this neurochemical sensing technology with electrophysiology techniques, offering a dual-function, multi-channel
probe. This represents a critical proof-of-concept, foundational for both advanced research tools and prospective
medical device development. Dr. Zestos' preliminary endeavors have yielded innovative carbon coating
processes for metal electrodes and carbon fiber multielectrode arrays, both utilized with multichannel
potentiostats for enhanced FSCV neurochemical measurements. His techniques have notably showcased the
simultaneous measurement of neurotransmitters like dopamine, serotonin, and adenosine in both in vitro and ex
vivo settings. Moreover, these carbon-based approaches have demonstrated superior sensitivity compared to
traditional methods, presenting a promising direction for future applications.
In this two-year STTR, Dr. Zestos is partnering with Spike Neuro to combine his carbon coating techniques with
Spike Neuro’s electrophysiology Silicon microelectrodes (SiME) to create a dual-function neurochemistry and
electrophysiology microelectrode. This work will also explore recent promising developments with the use of
Silicon-Carbide microelectrodes (4H-SiCME) for both neurochemistry and electrophysiology function. 4H-
SiCMEs promise to offer a more robust and biocompatible material option compared to existing neurochemistry
and electrophysiology electrode materials. The project is structured around two primary aims.
Aim 1 will concentrate on refining the carbon deposition process for SiMEs, optimizing contact size, and
evaluating longevity and function.
Aim 2 efforts will pivot to the development of 4H-SiCMEs, addressing inherent production limitations, evaluating
the use of pyrolyzed photoresist glassy carbon contacts, and assessing the utility of the wider water window
provided by Silicon-Carbide for enhanced neurochemical detection.
Spike Neuro will commercialize one or more designs from this work as a research tool as part of their existing
product line while continuing to work with Dr. Zestos toward clinical applications for the development of a multi-
biomarker closed-loop stimulation system.

Public health relevance
Narrative Many neurological disorders and diseases have both electrophysiology and neurochemical etiologies; however, these biomarkers are rarely studied in tandem due to the lack of available tools. There is a critical need for neuroscience tools that enable multi-channel, high temporal recording of multiple neurochemicals and electrophysiology signals simultaneously to support the development of clinical multi-biomarker, closed-loop stimulation systems for the study and treatment of neurological conditions including Parkinson’s Disease, epilepsy, depression, drug abuse, and other neurological disorders. Dr. Alexander Zestos of American University and Spike Neuro are partnering together to develop carbon modified Silicon and Silicon-Carbide microelectrodes for dual-function neurochemistry and electrophysiology recording to address these gaps in the field.